Career Enhancement Core

ABSTRACT
The Career Enhancement Core (CEC) will be responsible for implementing innovative programs to enhance
collaborations, training, education, recruitment of new investigators, and community outreach. The CEC with
work closely with the Leadership Administrative Core (LAC) to carry out the specific aims of the CEC,
specifically overseeing the implementation of the pilot and feasibility programs to provide seed grant funding,
the recruitment and mentoring of young investigators, organization of educational conferences and community
outreach. The specific aims of the CEC are: 1) To provide seed grant funds for innovative research relevant to
the overall SCORE mission and the UCLA SCORE research program leading to extramural funds, 2) To recruit
and foster the career development of students, trainees and junior investigators who conduct research focused
on sex differences or women's health in brain-gut disorders, 3) To facilitate and promote collaboration between
the UCLA SCORE and other academic programs involved in women's health education and research, and 4)
To promote the importance of sex as a biological variable (SABV) through community outreach using
collaborative and innovative approaches. The CEC will leverage existing pilot grant programs on campus by
providing supplemental funds to support novel translational research with a focus on sex differences in brain-
gut interactions and/or women's health. These grant programs provide support to a wide range of young
investigators from undergraduate students to junior faculty. Our Center has a longstanding history of
successfully recruiting and mentoring young investigators with over half being women, organizing educational
conferences and research meetings, and implementing community outreach to foster public awareness and
interest in brain-gut microbiome science. Using the same team and approach, we will also promote sex as a
biologic variable research with lectures, seminars and via social media which will contribute tremendously to
educating and raising public awareness on sex differences and women's health.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Irritable bowel syndrome (IBS) is a disorder affecting 30 million Americans and is thought to arise in part from problems in the way the brain and gut interact. This Core will provide innovative programs to enhance collaboration, training, education and recruitment of new investigators, and community outreach. It is therefore critical for the overall success of the projects in their efforts towards better understanding and treatment for IBS.